Catalytic Redox Reactions for Pharmaceutical Synthesis

PROJECT SUMMARY
Redox reactions are among the most important synthetic methods in organic chemistry, playing a crucial role in
the preparation of pharmaceuticals, natural products, and other bioactive compounds. Advances in catalytic
oxidation and reduction reactions targeted in this project will have broad impact across the drug discovery and
development pipeline. Many existing catalytic redox methods face challenges in their efficiency and selectivity,
including chemo-, regio- and stereoselectivity, limiting their use in both small- and large-scale applications. The
proposed research will further develop oxidation, reduction, and coupling methods that form carbon-carbon and
carbon-heteroatom bonds. New C(sp3)–H functionalization/diversification reactions will streamline the discovery
of new bioactive molecules with diverse three-dimensional architectures, addressing key challenges in medicinal
chemistry and drug discovery, while others will provide the basis for streamlined process-scale synthesis of
pharmaceuticals. Four complementary project directions are highlighted in this proposal. The first focuses on the
synthesis and functionalization of “synthetic linchpins” derived from C(sp3)–H bonds to enable rapid access to
pharmaceutically relevant compounds. New methods will be developed to access versatile synthetic linchpins,
especially those that may be integrated with Ni-catalyzed cross-electrophile coupling to form C(sp3)–C(sp2) and
C(sp3)–C(sp3) bonds. The second project will develop new electrosynthetic methods, including both oxidation
and reduction reactions. These efforts will build upon our use of electrochemical mediators to facilitate new
oxygenation, cross-electrophile coupling, deoxygenation, dehydration, radical chain, and biocatalytic reactions.
We will use our expertise to develop electroanalytical methods that support optimization of catalysts and
conditions for these reactions. The third project will apply chemistry developed in the first two projects to the
synthesis of drug metabolites, in addition to developing new nucleophilic oxidation methods that mimic aldehyde
oxidase metabolism. Development of a ‘metabolite synthesis toolbox’ will address a major bottleneck in drug
development. Finally, we will develop heterogeneous catalysts for aerobic oxidation and oxidative coupling
reactions that address unmet synthetic challenges, such as formation of N–N and N–O bonds, and provide
opportunities for practical application in large-scale synthesis of pharmaceutical intermediates and APIs. Close
interactions and collaborations with multiple academic groups and pharmaceutical companies in all phases of
this project will play an important role in ensuring the broadest possible impact of our efforts.

Public health relevance
PROJECT NARRATIVE Chemical reactions that add or remove electrons from organic molecules play a crucial role in the discovery and manufacture of pharmaceuticals. The research outlined in this proposal will develop new catalysts and synthetic methods capable of using molecular oxygen and electricity to support drug discovery and sustainable processes for large-scale synthesis of pharmaceuticals.